Interrogating the RIP kinase function of LRRK2 in chronic inflammation and susceptibility to infection.

Project Summary
Human genetic variants associated with mitochondrial dysfunction have been linked to chronic inflammatory
diseases as well as susceptibility to infection. However, the mechanistic impact that these variants have on the
immune system is poorly understood. I have discovered that macrophages harboring the common Parkinson’s
disease associated variant, Lrrk2G2019S are more prone to cell death in response to both Mycobacterium tuber-
culosis (Mtb) infection and AIM2 inflammasome activation. The enhanced cell death in Lrrk2G2019S macrophages
is marked by mitochondrial stress and accumulated mitochondrial ROS. Interestingly Lrrk2G2019S cells are pushed
from undergoing pyroptotic cell death to RIPK3/RIPK1/MLKL-mediated necroptosis. Consistent with elevated
necroptotic cell death, infection of Lrrk2G2019S mice with Mtb elicits dramatic hyperinflammation and exacerbated
pathogenesis via enhanced neutrophil infiltration. While these findings demonstrate that altered cellular homeo-
stasis can reprogram canonical innate immune and cell death pathways to elicit distinct immune outcomes, the
mechanistic contribution of the LRRK2-G2019S mutation on enhanced cell death remains a black box.
Defining precisely how the Lrrk2G2019S variant promotes necroptotic cell death will help us to better understand
why it is associated with susceptibility to chronic inflammatory and infectious diseases. Importantly, the
Lrrk2G2019S variant has been shown to have enhanced RIP kinase activity. Additionally, previous studies have
linked RIPK1 to LRRK2 as a potential substrate. I therefore propose that increased kinase activity conferred by
the G2019S variant promotes a shift towards necroptotic cell death during pyroptosis by directly facilitating the
activation of the RIPK1/RIPK3/MLKL signaling axis. To test this model, this proposal employs a cell biology
(Aim 1) approach to identify kinase dependent interactions between LRRK2 and its substrates during pyroptosis
and necroptosis, and an in vivo modeling (Aim 2) approach to observe which cell populations are undergoing
necroptosis and identify the minimal requirements driving hyperinflammation. The goals of experiments de-
scribed in this proposal will: 1.) uncover novel biology at the interface of cell death modalities, 2.) identify mech-
anisms through which LRRK2 regulates and promotes cell death and inflammation, and 3.) map inflammatory
phenotypes to connect in vitro biology with disease in vivo. The tools, training, and expertise described in
this proposal will provide me with the experience necessary to establish a successful independent re-
search program designed to interrogate how genetic mutations associated with mitochondrial dysfunction and
chronic disease impact cell death programs in the immune system to drive pathogenesis.

Public health relevance
Project Narrative LRRK2, also known as RIPK7, plays a central role in Parkinson’s disease (PD) progression and susceptibility to mycobacterial infection. Although RIP kinases are critical regulators of proinflammatory cell death, including pyroptosis and necroptosis, the role of LRRK2’s RIP kinase activity in these pathways has been neglected. My work will mechanistically connect LRRK2’s RIP kinase function to the regulation of proinflammatory cell death modalities, and determine how genetic variants of LRRK2 dysregulate these pathways to promote inflammation, infection, and chronic inflammatory diseases including PD, Crohn’s disease, and cancer.